New advances to break the genetic tractability barrier of human Prevotella species

PROJECT SUMMARY
The Prevotella genus is one of the most abundant and diverse genera in the oral cavity, and includes numerous
prominent oral microbiome species that have been recognized for decades to play critical roles in mucosal health
and disease. Accordingly, recent culture-independent studies have found oral Prevotella species to be strongly
associated with a broad range of both oral and extraoral conditions, especially polymicrobial abscesses and
multiple types of malignancies. Despite this, shockingly little is known about the biology of all Prevotella species,
largely as a consequence of the notorious genetic intractability within the entire genus. Recently, we encountered
this same limitation due to our ongoing studies of host interactions with our Prevotella human odontogenic
abscess clinical isolates. While we have identified a variety of intriguing host interaction phenotypes, further
mechanistic studies of these phenomena have been stymied by the lack of options for Prevotella genetic
manipulation. Consequently, we have recently focused our attention on genetic system development for oral
prevotellae. In our preliminary studies, we provide evidence of natural competence from 20 fully sequenced
abscess clinical isolates of P. melaninogenica, and we have been able to exploit this ability to genetically
manipulate multiple strains using cloning-independent methodologies. Furthermore, preliminary evidence
suggests that the P. melaninogenica DNA uptake apparatus is likely to represent an entirely new class of natural
competence machinery. Thus, we hypothesize that P. melaninogenica natural competence can serve as a model
to break the genetic tractability barrier within the Prevotella genus and reveal the genetic basis for its natural
competence ability.
The goals of this project will be achieved in two Specific Aims that: 1) characterize the natural competence ability
of oral Prevotella and 2) develop a complete genetic toolbox for detailed genetic studies of oral Prevotella.

Public health relevance
PROJECT NARRATIVE The Prevotella genus is one of the most prevalent genera in the human oral microbiome, and contains numerous prominent species associated with oral health and disease. Despite their significance in the oral cavity, all Prevotella species remain understudied and poorly characterized due to the genetic intractability throughout the entire genus. This study aims to overcome this longstanding genetic barrier and develop new tools that will support detailed investigations of Prevotella genetics.